Mechanisms of energy storage in lipid droplets

Project Summary/Abstract
In eukaryotes, energy is stored primarily as highly reduced triacylglycerols (TG) in membrane-less organelles
called lipid droplets (LD). A central question for the field is what protein machinery evolved to efficiently and
reproducibly make these emulsion particles in cells for storing lipids. Starting with our screens to identify genetic
components of this process, our work has helped to shape the current understanding of LD formation, including
elucidating the molecular structure and mechanism for a TG-synthesis enzyme (DGAT1), the components and
structural information for seipin and the ER-based LD assembly complex (LDAC), and molecular insights into
ER enzymes that modify this process, such as FIT2. The current proposal builds on our progress and proposes
to overcome key knowledge gaps for each of these aspects of LD formation. We will extend our studies of TG
synthesis to elucidate the structure, biochemical function and cell biological functions of the DGAT2 enzyme,
which is closely linked to de novo fatty acid synthesis and a drug target that is in phase 2 trials for fatty liver
disease. We will obtain a structure of the complete LDAC, including the key protein LDAF1, and utilize
biochemical and molecular dynamics simulations studies to test models of how the LDAC facilitates LD
formation. Finally, we will study the LD modifier, FIT2, to test the hypothesis that this enzyme plays a key
functional role in providing CoA for mitochondrial metabolism. Achieving our goals will provide leading edge data
to unravel the molecular machinery that underlies lipid and energy storage in cells and will help to elucidate the
pathogenesis of diseases with alterations in lipid storage.

Public health relevance
Project Narrative Life depends on energy storage, and in cells the primary means to store energy is as triglyceride oils in organelles called lipid droplets. Disorders of lipid storage in cells or tissues is associated with diseases, such as obesity, fatty liver disease, and atherosclerosis. This proposal aims to unravel how lipid droplets are made at the molecular level, laying the groundwork for understanding related aspects of energy storage in physiology and disease.